Optimizing a dyadic physical activity intervention for Hispanics with osteoarthritis and their physical activity supporter

PROJECT SUMMARY/ABSTRACT
Hispanics are less likely to meet physical activity guidelines and those with osteoarthritis are more likely to report
greater joint pain, functional limitations, and work limitations than non-Hispanic Whites. Among Hispanics, social
and cultural factors are important intervention considerations because of the value placed on interdependence
over independence in traditional Hispanic culture. It is hypothesized that culturally sensitive PA interventions
designed for Hispanics offer potential to reduce disparities in physical activity and therefore OA symptoms. This
study will adapt the self-administered 6-week walking intervention for Hispanics with osteoarthritis, Camine con
Gusto (Walk with Ease) for dyads consisting of Hispanics with osteoarthritis and a member of their social network
who supports their physical activity attempts (“supporter”). Developing a dyadic physical activity intervention
shaped by the cultural value of interdependence will engage Hispanics with osteoarthritis and their supporters
equally, thus positively influencing each other’s physical activity and providing greater osteoarthritis symptom
relief. Two aims will achieve the overall goals of the proposed study: 1) Develop four candidate dyadic
components targeting PA and OA symptoms; and 2) Determine the initial efficacy of the components using a
randomized pre-post pilot study. Under the first aim, four dyadic intervention components will be developed with
the input from a stakeholder panel and guidance from the mentoring team. Five intervention conditions will be
tested for acceptability and feasibility of implementation (N= 10 dyads per condition). Four conditions will include
one of the candidate components + Camine con Gusto and the fifth condition will include all candidate
components + Camine con Gusto. Based on qualitative and quantitative assessments and stakeholder panel
feedback, the four dyadic intervention components will be revised in preparation for Aim 2. Under the second
aim, a randomized factorial design will be implemented to determine the initial efficacy of the dyadic intervention
components on the daily steps of Hispanics with osteoarthritis. The factorial design will pilot test conditions
consisting of different combinations of the components that when added to Camine con Gusto demonstrate initial
efficacy in daily steps over six weeks. This aim will also allow for the examination of the reciprocating influences
between Hispanics with osteoarthritis and their physical activity supporters on each other’s daily steps using
dyadic analysis (actor-partner interdependence model). The proposed study will address several limitations of
previous interventions by a) focusing on Hispanics with osteoarthritis, and b) examining an array of dyadic
components separately to determine those components that should be retained in a future trial. Findings will
inform a randomized controlled trial via a future R01 to evaluate the efficacy of the optimized dyadic intervention
package containing only “active” components.

Public health relevance
PROJECT NARRATIVE This proposal intends to use innovative methods to rigorously develop a dyadic physical activity intervention among Hispanics with osteoarthritis (OA) and a friend/family member who supports their physical activity (PA) efforts. This study’s contributions are significant because it addresses the need for interventions promoting PA among Hispanics with OA by incorporating their social environment, thus using a culturally sensitive approach to improve health behaviors. Optimizing the dyadic intervention components that demonstrate initial efficacy on daily steps will inform a future randomized controlled trial to increase PA and relive symptoms among Hispanics OA.